APOE as a modifier of prion-like spread in dementia

Title: APOE as a modifier of prion-like spread in dementia Abstract: The overall objective of this multidisciplinary project is to test the hypothesis that relative to APOE2 or APOE3, APOE4 facilitates the seeding and spread of misfolded Aβ, tau, and α-synuclein (αSyn). Inheritance of an APOE4 allele increases the risk of developing Alzheimer's disease (AD) dramatically. Most studies suggest that the primary mechanism by APOE increases the risk for AD is by modulating the deposition of Aβ peptide. However, there are studies that suggest APOE may also directly modulate the phosphorylation and misfolding of tau. Although APOE genotype is not recognized as a risk factor allele for the pure αSyn-opathies, such as Parkinson's disease (PD) the presence of an APOE4 allele has been shown to increase risk of dementia in PD by some studies. In vitro, APOE can directly modulate the aggregation of αSyn. Somewhat surprisingly, although the first descriptions of Aβ seeding in mice were reported more than 10 years ago and various human APOE models have been available for many years, there have been no studies of how APOE genotype may modulate seeding of Aβ. Similarly, there has been no study of how APOE genotype may influence tau or αSyn seeding. We now propose three Aims to conduct a thorough and systematic assessment of how different isoforms of human APOE impact the prion-like seeding of Aβ, tau and αSyn, with focus on assessing whether different APOE isoform may interact with these aggregating proteins to produce distinct strains of misfolded Aβ, tau, or αSyn. Aim 1 will determine the relative ability of APOE2, APOE3 and APOE4 to support the seeding of Aβ pathology, and whether APOE isoform modulates the strain characteristics of the seeded Aβ aggregates. Aim 2 will determine whether ApoE genotype influences the severity or spread of CNS tau pathology. Aim 3 will determine the impact of ApoE genotype on the seeding and transmission of αSyn. Collectively, these studies will produce a unique repertoire of animal models and provide the first assessment of whether different human ApoE isoforms may be influencing that pathogenesis of AD and DLB by modulating the prion-like seeding of amyloid, tauopathy, and α-Synopathy.

Public health relevance
Narrative There are three variations of the gene for apolipoprotein E in humans, abbreviated APOE2, APOE3, and APOE4, and inheritance of the E4 variant significantly increases the risk of developing dementia. The mechanism underlying this risk is incompletely understood. A hallmark of dementia is the accumulation of misfolded forms of the proteins; β-amyloid peptide, tau, and α-synuclein. Using well-established mouse models of these pathologies, the overall objective of this project is to test the hypothesis that relative to APOE2 or APOE3, APOE4 facilitates the initiation and progression of these pathologies driving neurodegeneration.